Circadian clock regulation of metabolic pathways in aging

Project Summary
Sarcopenic obesity (SO), the loss of skeletal muscle mass and function with obesity in old age, are debilitating
co-morbidities contributing to increased mortality in this population. Our current understanding of the
mechanisms underlying these metabolic deficits and targeted therapeutic options are limited. Circadian clock
exerts temporal control in key metabolic processes that underlie cellular senescence in aging, and its disruption
leads to the development of obesity, Type II diabetes and early aging. Despite the importance of circadian
regulation involved in metabolic homeostasis, how aging impacts clock metabolic output and their potential
contribution to aging-associated metabolic decline remains unknown. Prior studies indicate intricate interplays
between circadian clock and aging, with loss of clock leading to an early aging phenotype and aged stem cells
inducing re-programming of circadian pathways. In addition, our work revealed that muscle and adipose tissue
clock are required for developmental and metabolic processes that determined their metabolic capacity in
nutrient oxidation and storage respectively, while new results from shiftwork-induced clock disruption revealed
progressive muscle atrophy with adipose tissue expansion resembling SO. Based on further findings of
significant clock dampening with impaired output signaling in aged skeletal muscle and adipose tissue, we
hypothesize that circadian clock and its rhythmic metabolic output are required to maintain metabolic capacity in
skeletal muscle and adipose tissue to prevent SO in aging. Employing transcriptomics and metabolomics
approaches and leveraging unique tissue-selective clock loss- and gain-of-function models, we will
comprehensively define clock-controlled pathways underlying SO, and most importantly, further interrogate
clock-targeting strategies through genetic, lifestyle and pharmacological interventions. With the wide-spread
circadian misalignment in the elderly, the outcome of this project may uncover previously unexplored circadian
etiologies underlying SO and identify potential clock-targeting interventions to address these debilitating
metabolic co-morbidities of aging.

Public health relevance
Project Narrative The outcome of this project will elucidate circadian etiologies underlying aging-associated sarcopenic obesity and identify clock-modulatory interventions. Given the wide-spread circadian misalignment in the elderly, the proposed studies have translational values for clock-targeting strategies to alleviate the debilitating metabolic co-morbidities in the aging population.